Role of post-transcriptional regulation on cortical cell fate specification

Project Summary:
The central nervous system contains a myriad of different cell types that, in the right numbers and at the right
positions, receive and integrate information from the environment to generate the appropriate biological
responses. Failure to produce the right composition of cells can result in several mental and physical diseases
that range from cognitive disorders to severe brain malformations. In the neocortex, a specialized pool of neural
progenitors -called radial glial cells- gives rise to all types of projection neurons in a conserved temporal
sequence. The textbook’s view has been that the ability of the neural progenitors to produce different subtypes
of neurons is controlled by an intrinsic cascade of transcription factors that restrict progenitor competence over
time. However, there are reasons to question this model and in fact, the molecules responsible for the
synchronization of fate acquisition with developmental time remain elusive. Importantly, published and
preliminary data indicate that microRNA (miRNA) levels also affect neuron fate determination in a cell-
autonomous manner, highlighting the previously overlooked importance of posttranscriptional mechanisms in
cortical development. Here, we propose to unbiasedly uncover the dynamics of miRNA expression and the
mRNAs targeted by miRNAs pairs in neural progenitors over time using miR-eCLIP. We will further unveil
relevant molecular mechanisms regulated by miRNA-targeted mRNAs, and, in particular, their effects on RNA
methylation and how such RNA modification affects PN fate specification. Overall, the proposed research will
define the miRNAs and their target mRNAs involved in cortical cell fate acquisition and shed light on the
molecular mechanisms regulated by this important post-transcriptional mechanism.

Public health relevance
Project Narrative: Neural progenitors in the neocortex give rise to the different classes of projection neurons and glia in a conserved order, but the molecular mechanism(s) coordinating cell fate determination with developmental time remains unknown. We hypothesize that a pathway involving miRNAs is responsible for controlling the changes in RGC competence and further propose a broad role for posttranscriptional regulation in cortical cell fate specification.